PROFESSIONAL DEVELOPMENT

The overall goal of Professional Development Core (PDC) is to integrate clinical and translational research training and professional development activities across the participating institutions. In collaboration with other PRCTRC cores and research programs PDC will support post-doctoral level professionals and junior faculty to become successful researchers addressing minority health and health disparities.